Training in Psychopharmacology and Outcomes Research

Use continuation pages as neededto provide Start with Principal Investigator. List all other key personnel in alphabetical order, last Name Organization Eric Hollander, M.D. Mount Sinai School Jack Hirschowitz, M.D. Mount Judith Neugroshl, M.D. Mount Monte Buchsbaum, M.D. Mount Joseph Buxbaum, Ph.D. Mount Kenneth Davis, M.D. Mount Disclosure Permission Statement. Applicable to SBIR/STTR + PHS 398 (Rev. 05/01) Sinai School Sinai School Sinai School Sinai School Sinai School York, New York the required information in the name first. of Medicine of Medicine of Medicine of Medicine of Medicine of Medicine format shown below. Role on